Uncovering Novel Microbial Factors That Enhance Wound Repair

Skin injuries and repair failures are a significant public health concern, with over 100
million new acute skin wounds occurring annually and non-healing wounds affecting 2% of the
U.S. population. The economic burden of wound management is substantial, with annual
treatment costs exceeding $25 billion. Despite this impact, effective interventions to improve skin
healing outcomes remain elusive. Skin injuries expose internal organs to environmental threats
and allow the translocation of surface microbes. While the pathological role of microbes in non-
healing wounds is well studied, their contribution to acute healing and the potential of specific
microbial factors to serve as pro-repair signals remain unclear.
We and others have shown that signals from the skin microbiome can modulate cutaneous
immunity and barrier function, suggesting that microbially-derived signals may also enhance
repair. Our strong preliminary data show that several Staphylococcal species are enriched in
acute human wounds. Using an in vivo screen with a newly developed physiological microbial
translocation wound model, we identified specific Staphylococcal species that enhance repair
four-fold without causing infection. Loss-of-function bacterial genetics revealed that enhanced
Staphylococcal-driven healing depends upon toxin production. We hypothesize that
Staphylococcal toxins act as novel pathogen-associated molecular patterns for repair by
modulating both epidermal and dermal repair processes. Aim 1 will identify the specific toxins and
epithelial responses involved in promoting repair, while Aim 2 will investigate how microbial toxins
drive dermal repair responses. This research will leverage cutting-edge spatial omics
technologies, including spatial transcriptomics and spatial lipidomics, combined with rigorous
bacterial genetics and in vivo functional studies in repair. Our efforts promise to uncover non-
canonical microbial mechanisms that enhance skin repair, potentially leading to innovative
microbe-based therapies to boost this fundamental process and increase barrier fitness.

Public health relevance
Skin injuries and repair failures affect millions annually, yet therapeutic advances remain elusive. Our research suggests that signals from the skin microbiome, particularly from certain Staphylococcal species, can enhance wound repair without causing infection. Here we propose to identify specific Staphylococcal factors that enhance repair by modulating epidermal and dermal processes, which could lead to innovative microbe-based therapies for skin healing.